Innovations in Personalizing Treatment for Eating Disorders Using Idiographic Methods and the Impact of Personalization on Psychological, Physical, and Sociodemographic Outcomes

Abstract
Eating disorders (ED) are serious psychiatric illnesses associated with various medical and functional
complications. It is unknown which specific cognitive-affective mechanisms driving EDs impact the
development of medical and functional complications, and whether targeting these mechanisms through
personalized treatment leads to better outcomes than existing “one-size-fits-all” interventions. Furthermore, it is
unclear how social determinants of health (SDOH) impact the heterogeneity of EDs and how they should best
be integrated into treatment. The long-term research goal of the diversity supplement candidate, Mr. Juan
Hernandez, is to created new innovative, efficacious, and cost-effective personalized ED treatments for diverse
communities. Consistent with this goal, the current Diversity Supplement proposes to use idiographic network
modeling to examine individual differences in ED symptom presentations and test whether a personalized
intervention approach outperforms existing front-line treatments (i.e., CBT-E). The current proposal builds on
the parent grant (DP2MH136495) and will uniquely contribute to the literature by examining how individual
differences in EDs are associated with medical and functional complications and SDOH, each of which directly
impact longevity and quality of life. Grounded in existing literature, we hypothesize that central cognitive-
affective mechanisms will vary across individuals and will be more associated with medical disorders and
functional outcomes (i.e., health-related quality of life, physical functionality and vitality, health perceptions,
achievement of self-defined goals) than behavioral symptoms. We also hypothesize that more disadvantaged
SDOH (e.g., more severe food insecurity, more experiences of marginalization) will also be associated with
more medical disorders and worse functional outcomes. As per treatment effects, we hypothesize that at post-
treatment, the personalized treatment condition will be associated with less medical disorders and better
functional outcomes compared to the front-line treatment condition. Lastly, we hypothesize that at post-
treatment, the personalized treatment condition will not be as impacted by SDOH as front-line treatments
across medical and functional outcomes. This study will be the first to examine (a) individual differences in EDs
impact on medical and functional complications and (b) how to best incorporate SDOH into ED treatment to
address medical and functional complications. Results will inform important etiological and treatment questions
that will directly inform efforts to promote longevity and quality of life among those experiencing an ED. The
conceptual, quantitative, and professional rigor of the training plan will prepare Mr. Hernandez to meet his
long-term goal of conducting clinical ED research at a Research 1 University. With the post-doctoral training
from this supplement, Mr. Hernandez will increase diversity of the field and fill a crucial role as an independent
clinical science researcher and translational health psychologist.

Public health relevance
Project Narrative Existing eating disorder treatments lack the flexibility to adapt to individuals’ symptom and environmental complexities. Further, it is unknown how individual differences impact associated medical and functional complications. This diversity supplement to DP2MH136495 will lead to personalized eating disorder treatment that accounts for social determinants of health, medical comorbidities and functional complications, while providing crucial post-doctoral fellowship training to the diversity supplement awardee.